Multimodal assessment of social disconnection as a proximal risk for suicide ideation in late life.

Abstract/Project Summary
Globally, and in the United States, older adults exhibit the highest rates of suicide deaths. Research has shown
that social disconnection and interpersonal negative life events (NLEs) are both significantly linked with suicide
ideation, attempts, and deaths in late life, yet few studies have examined moderators of the relationship
between social disconnection and suicide ideation or considered social disconnection as a mediator of the
relationship between interpersonal NLEs and suicide ideation in late life, despite compelling evidence to do so.
In addition, existing studies are mostly cross-sectional and provide little insight into how suicide risk unfolds
over hours, days, weeks, and months in older adults. The overarching goal of this proposal is to leverage a
multimodal assessment of behavioral and social mechanisms to improve our ability to identify specific
predictors relating social disconnection to suicidal ideation in late life. We will examine how a crucial social-
cognitive vulnerability, rejection sensitivity (RS), moderates the relationship between social disconnection and
suicidal ideation in late life. RS is the predisposition to subjectively perceive, anxiously expect, and intensely
react to social rejection, and reflects the Research Domain Criteria (RDoC) of Social Processes: Affiliation and
Attachment. Using an intensive longitudinal design over the course of 1-year, we will also examine social
disconnection as a mediator of the relationship between interpersonal NLEs and suicidal ideation over different
timescales. Participants will include a diagnostically diverse sample of 250 men and women ages 60 and older
who report elevated suicidal ideation. Multimodal assessments will include interviews, self-report measures,
two laboratory-based social rejection paradigms, and a 14-day ecological momentary assessment (EMA)
protocol. Follow-up assessments will be conducted every 3 months over the course of 1-year to fully assess
rare, low base rate interpersonal NLEs (e.g., death, illness, loss of relationships), and the 14-day EMA protocol
will be repeated at 6-months and 12-months. The proposed project has two specific aims: 1) to investigate RS
as a static and time-varying moderator of the relationship between social disconnection and suicidal ideation in
late life; and 2) to examine the mediating effect of social disconnection on the relationship between
interpersonal NLEs and suicidal ideation in late life. Results will aid in the development of evidence-based
personalized treatment recommendations targeting key dimensions of social disconnection, rejection
sensitivity, interpersonal NLEs, and suicidal ideation in late life.

Public health relevance
Project Narrative Suicide in late life represents a significant public health problem with rates among individuals ages 65 and older reported to be the highest in almost all regions of the world, including the United States. This research will contribute to our understanding of the relationship between social disconnection and suicidal ideation in late life, with direct implications for suicide risk assessment and personalized treatment recommendations targeting social processes.